Molecular Regulation of Lineage Specification of the Mouse Cerebellum

SUMMARY
In addition to its sensory-motor processing, the cerebellum is also involved in higher cognitive
function. Accordingly, cerebellar pathology and dysfunction are linked to many debilitating developmental
diseases like autism spectrum disorder and other intellectual deficits. Studying the generation of the
proper number and diversity of neurons and glia in the cerebellum will advance our knowledge of the
assembly of cerebellar circuits and the cellular basis of cerebellum-related disorders. During
embryogenesis, various GABAergic cerebellar neurons, such as Purkinje cells, interneurons of deep
cerebellar nuclei and the cerebellar cortex, arise from the cerebellar ventricular zone in defined
developmental windows. By contrast, cerebellar glutamatergic neurons arise from the cerebellar rhombic
lips, the second germinal zone, at the interface between the ventricular zone and roof plate of the forth
ventricle. The molecular mechanisms underlying the generation of different cerebellar cell types are
incompletely understood. In particular, how the rhombic lip gives rise to cerebellar nuclear neurons,
granule cells and unipolar brush cells in temporally restricted orders, and how precursors for different
cerebellar nuclei, which form the sole output of the cerebellum, are largely unknown. We propose to use
single-cell RNA-sequencing (scRNAseq) to investigate the developmental programs underlying cell
specification and differentiation in mouse cerebellar anlage. A pilot study of mouse cerebella at embryonic
day (E) 13.5 has demonstrated the feasibility and power of scRNAseq in classifying cell types or cell
states, and reconstructing developmental trajectories. The specific aims of the application as follows: 1.
Define the cellular composition and lineage relationship in the mouse cerebellum. To test the
working hypothesis that cerebellar cell types acquire coherence molecular signatures at cell birth, we will
perform large-scale quantitative scRNAseq to identify cell populations and their defining molecular
features in mouse cerebella between E11.5 and adult. The scRNAseq data will be used to infer the
trajectory of cell lineages. Histological analyses will be performed to validate and define the
spatiotemporally controlled birth and migration of various cell groups identified by scRNAseq. The
histological studies will be augmented by characterizing mouse mutations that target defined lineages. 2.
Determine the molecular mechanism underlying the specification of cerebellar nuclei. To test our
working hypothesis that transcription factors Meis2, Pax6, and Olig2 control the development of cerebellar
nuclei, we will use electroporation assays in chick and mouse embryos, and mouse genetics to determine
how gain- or loss-of-function of these transcription factors affects the specification of cerebellar nuclei.

Public health relevance
PROJECT NARRATIVE This proposal seeks to study how the great diversity of cerebellar neuronal and glial cells arises during embryogenesis. Determining the developmental trajectory by which molecularly distinct cell types are produced and assembled into cerebellar circuits will be central to understanding developmental cerebellar disorders associated with autism, and other intellectual and motor deficits.